Enhancing experimental rigor through education in evidence synthesis

PROJECT SUMMARY/ABSTRACT
More research is being published now than any other time in history and that research is accessible worldwide.
Due to the rapid proliferation of research, it can be difficult if not impossible for an individual to stay abreast of
important findings which can impact research and evidence-based practice. Yet, having a comprehensive
understanding of the literature is foundational to advancing knowledge. This allows a researcher to identify
existing gaps in knowledge so that they can design new research to advance the area forward. One way to
achieve this is through a rigorous evidence synthesis, or a systematic approach to gathering and analyzing
results from multiple sources. In practice, the use of evidence syntheses requires improvement, as they are often
poorly conducted and reported, which has serious downstream impacts on public health. While there are ample
resources currently available to researchers on the topic, they are underutilized and may not be fully accessible
to all individuals who may benefit from them.
The National Institute of Neurological Disorders and Stroke (NINDS) seeks to improve fundamental knowledge
through timely dissemination of scientific discoveries in the area of neurological disease. This mission, across
the translational spectrum, is fully supported by enhancing skills in evidence synthesis, which can prevent waste
in research investment. As knowledge of the brain and nervous system advances rapidly, scientists in this area
have to be highly reflexive to changing current knowledge to ensure that their work is relevant. Training in the
skills of evidence synthesis enables this.
Accordingly, the aim of this proposal is to develop, evaluate, and disseminate a series of educational modules
on rigorous approaches to science focused on evidence synthesis. The proposed modules will cover (1) an
introduction to evidence synthesis, (2) developing a research question and proposal, (3) designing literature
searches, (4) conducting an evidence synthesis, (5) analyzing data from an evidence synthesis, and (6) reporting
results from an evidence synthesis. The modules will be designed to be utilized by different levels of learners
(introductory, intermediate, and advanced) and apply across the translational spectrum (basic science, clinical
science, and public health). Module development, evaluation, and dissemination will occur with an iterative
process of review and feedback across multiple stakeholders (experts and lay persons alike) to create a useful
and comprehensive final product.
The opportunity to improve the use of evidence synthesis techniques through a platform that is accessible to all
interested scientists has significant potential to enhance scientific rigor, and ultimately, improve public health.

Public health relevance
PROJECT NARRATIVE Every researcher benefits from understanding what has been done previously by other scientists prior to beginning their own scientific investigation. The proposed project, the creation of freely available educational modules on the topic of evidence synthesis, aims to help scientists do this. Creating better literature review skill sets among scientists means less wasteful research is generated and a higher likelihood of improving public health.